POG 9572 - PHASE I TRIAL OF BRYOSTATIN 1 IN CHILDREN WITH SOLID TUMORS

The purpose of this study is to determine the maximum tolerated dose and side effects of bryostatin 1 given as a one-hour infusion in pediatric patients whose cancer does not respond to standard therapy.